PET and MRI Evaluation of Cerebral Inflammation and Metabolic Stress in Relapsing Multiple Sclerosis

ABSTRACT
Multiple sclerosis (MS) is an immune-mediated, demyelinating, and degenerative disease of the central
nervous system and is a leading cause of disability in young people. Most patients begin with a relapsing-
remitting (RRMS) course. Clinical relapse and new white matter lesion formation is dramatically reduced by
current therapies. However, despite evidently efficacious treatment of RRMS, many patients eventually
develop progressive MS (PMS) wherein disability accumulates refractory to treatment. Progressive disability is
driven by neurodegeneration which begins early in the disease, occurs independent of relapses, and is poorly
understood. Two potential contributors to neurodegeneration are subclinical inflammation and metabolic stress.
Clinical relapses and new lesion formation are driven by inflammatory demyelination, but additional
inflammation is present outside of discrete lesions. This inflammation is associated with chronic demyelination
and increased metabolic demand. Both inflammation and metabolic stress may lead to neurodegeneration,
either alone or in combination.
This study will use a novel positron emission tomography (PET) imaging agent, 11C-CS1P1, which binds to
sphingosine-1-phosphate-receptor 1 (S1PR1) as a marker of inflammation. S1PR1 signaling is critical to MS as
evidenced by four FDA approved S1P-modulators with high efficacy for reducing relapses in RRMS.
Additionally, we will use metabolic imaging with 18F-FDG PET and advanced, oxygen-sensitive magnetic
resonance imaging (MRI) to measure cerebral glucose and oxygen utilization, respectively. These
measurements will be made in a cohort of heathy control participants, RRMS patients who will be initiating an
S1P-modulating drug and RRMS patients initiating a similarly efficacious non-S1P-modulating drug (B-cell
depleting therapies). Patients will be imaged prior to and 3-months following initiation of treatment. These data
will allow for testing the hypotheses that subclinical inflammation and metabolic stress are present in RRMS
and are incompletely mitigated by current treatments. This study will address three Specific Aims. The first aim
tests the hypothesis that inflammation is increased outside of MS lesions in seemingly normal appearing tissue
and is reduced by S1P-modulation. The second aim will examine the metabolic needs and stress of normal
appearing white matter and gray matter in MS patients compared to controls. The first two aims will compare
their respective biomarkers pre- vs. post-initiation of an S1P-modualting drug. The final aim investigates how
S1PR1 expression and metabolic stress are modulated by an efficacious, but not S1P-modualting therapy.
Completion of this study will provide new understanding of processes that drive neurodegeneration in
MS and contribute to clinical morbidity and disability.

Public health relevance
Narrative Despite highly effective medications for the initial treatment of relapsing remitting multiple sclerosis (MS), many patients develop progressive MS wherein neurological disability accumulates despite medical treatment. We plan to investigate how brain inflammation and metabolic stress combine to contributes to MS pathophysiology using a combination of positron emission tomography (PET) and magnetic resonance imaging (MRI). Further understanding of the contributors to MS may uncover new treatment targets or allow for more precise monitoring of disease activity.